Experimental and Clinical Studies of Presbyacusis

PROJECT SUMMARY/ABSTRACT - OVERALL
The overarching goal of the proposed research is to advance our understanding of age-related hearing
loss (presbyacusis). More than 37 million American adults have impaired hearing and this number is rising
rapidly due to our growing aging society. Interventions for presbyacusis have relatively limited effectiveness,
due in part to our incomplete understanding of the distinct metabolic, sensory, and neural mechanisms
underlying hearing and communication difficulties in older adults. Four integrated scientific projects are
supported by a human subjects core and will test hypotheses about the pathophysiology and genetic,
molecular, and cellular mechanisms underlying presbyacusis, examine their consequences for communication,
develop tools that improve the diagnostic specificity of presbyacusis, and provide guidance for individualized
interventions. Project 1 identifies genetic variants for presbyacusis, characterizes their associated
pathophysiology, defines their effects on hearing loss, and assesses the pathologic consequences of these
variants in human temporal bones. Project 2 examines how age-dependent changes in the cochlea's innate
immune system contribute to degeneration of the cochlear lateral wall and auditory nerve, leading to metabolic
and neural presbyacusis. Project 3 uses unique physiologic metrics shared with Project 2 that differentiate
metabolic, sensory, and neural presbyacusis in human subjects. Using these same subjects, Project 4
examines acoustic-level phonetic cue and executive system explanations for why older adults experience
speech recognition difficulties. Thus, the four scientific projects are interrelated and complementary across
levels of analysis to integrate data from animal models, human subjects, and human tissue for the extensive
characterization of the pathophysiology of presbyacusis from the inner ear to cortex. Core A (Administration)
provides and supports an administrative structure to integrate all scientific activities of the Clinical Research
Center. Core B (Human Subjects) recruits human subjects and coordinates their schedules, and supports
collection, storage, and analysis of data, which are shared with other research groups to confirm our findings
and extend the impact of our research. Together, the proposed research and comprehensive longitudinal
human subject database form a cohesive, translational program that will advance our understanding of human
presbyacusis and promote scientific progress through sharing of data and presbyacusis phenotyping tools. The
Clinical Research Center is unique because of its 30-year longitudinal study of hearing in older adults, clinical
and translational approaches, and a focus on providing strong evidence to enhance hearing health care for the
millions of Americans who have reduced quality of life because of poorer hearing and communication abilities.
The Center will continue to guide the theoretical and clinical study of audition and precision treatments for
presbyacusis.

Public health relevance
PROJECT NARRATIVE – OVERALL The Clinical Research Center leverages the multidisciplinary and wide-ranging expertise in each scientific project, and the wealth of information available in the human subject database, to generate new knowledge about the high-prevalence public health concern of age-related hearing loss (presbyacusis). Our long-term goals are to reduce its prevalence, slow its progression, and develop new prevention, diagnostic, and treatment strategies to improve communication and the quality of life of millions of older adults.